Genomic Data Science Core

ABSTRACT
The advent of next-generation sequencing (NGS) has revolutionized modern genomics, providing enormous amounts of new data at an unprecedented rate. Extraction of meaningful biological insights from these large, highly dimensional datasets demands careful application of bioinformatic, computational, and statistical analysis approaches. In Phase 2, the Genomics Data Science Core, (GDSC) will support development and implementation of novel approaches for analysis of -omics data, with special emphasis on single cell and spatial transcriptomic methods. To support recent investments made by the Single-Cell Genomics Core (SCGC), we will build specialized tools for spatial transcriptomics, an exciting new area that allows scientists to understand the detailed molecular changes in tissue architecture at a single-cell level. In addition, we will strengthen shared computing resources to support research in single cell and spatial omics and offer new educational workshops to train researchers in the latest data analysis techniques, particularly for single-cell and spatial omics data. We will develop computational resources that support cluster computing for multidisciplinary genomics research, including pipelines and software for novel applications, hosting of commonly used genomic references, and a new educational workshop for single-cell transcriptomics data analysis. Collectively, these goals position the GDSC to have a significant positive impact on genomics research within the CQB and greater Dartmouth community by enhancing accessibility to genomic data analysis services and training opportunities.